Comparing the effectiveness of telehealth to in-person delivery of a combined metacognitive and attention training in Veterans with mTBI/PTSD

Background. Over 70% of Veterans with mild traumatic brain injury (mTBI), seeking services at the Veterans’
Health Administration, suffer from comorbid post-traumatic stress disorder (PTSD). These Veterans commonly
experience concomitant executive dysfunction in goal setting, concentration, and attention that impairs their
performance in complex daily tasks. Others and we have studied Goal Management Training (GMT) to
address this problem. Collectively, the data have shown that GMT improved some aspects of executive
function in mTBI/PTSD but did not restore cognition to normal during complex tasks. Goal management for
performing complex tasks requires cognitive processes such as attention, and direct-attention training may be
beneficial in improving cognition. GMT with attention training have been used in other studies, but those did not
involve Veterans with either mTBI or mTBI/PTSD. We recently conducted a pilot study combining GMT and
direct-attention training (GMT+ATT) in Veterans with mTBI and PTSD. We discovered a large treatment effect
(Cohen d=2.23) in the NIH EXAMINER Executive Composite score and a significant treatment response in the
NIH EXAMINER Cognitive Control subdomain and the Unstructured Task.
GMT or ATT is typically administered in-person. In-person treatment can impose problems such as limited
treatment access, poor cost-effectiveness, and unexpected situations (like the COVID-19 pandemic). As an
alternative method, telehealth has been used increasingly to meet the need for care in Veterans living in rural
areas and during the pandemic. Telehealth delivery of cognitive interventions in Veterans with mTBI or with
PTSD has shown effectiveness that is comparable to that of in-person treatment. However, GMT+ATT has not
been studied in these Veterans. Therefore, we have recently developed the format for telehealth delivery of
GMT+ATT in Veterans with mTBI/PTSD. Our preliminary data demonstrate the feasibility of this delivery
platform and similar treatment outcomes as compared to in-person therapy.
Objective & Hypotheses. The objective of this randomized controlled trial is to determine and compare the
effect of in-person and telehealth delivery of GMT+ATT in Veterans with mTBI/PTSD.
Hypothesis 1a. In-person GMT+ATT will improve cognition vs. control group (Brain Health Workshop (BHW).
Hypothesis 1b. Telehealth GMT+ATT will improve cognition vs. BHW control group
Hypothesis 2. Telehealth delivery of GMT+ATT will produce response comparable to in-person treatment.
Primary measure. The NIH EXAMINER executive composite score will assess overall executive function with
subdomains such as complex task performance requiring goal management, as well as tests underlying
cognitive control such as attention and working memory. Secondary functional measures. 1) Unstructured Task
and 2) Test of Grocery Shopping Skills (ToGSS), which captures naturalistic real-world function. Exploratory
Objective. To study the capability of the Attention Network Task to predict treatment response to GMT+ATT.
Methods. 63 Veterans will be randomized to 10 weeks of in-person or telehealth delivery of GMT+ATT or
BHW control. Outcomes will be assessed at pre-, post-, 6 month-post and 1-year post-treatment. GMT and
ATT will each be provided in ten, weekly, 2-hour sessions (4hrs/week as combined).
Significance. This study uses a novel combinational treatment of GMT+ATT to restore the executive and
attentional processes required for complex daily tasks in Veterans with mTBI/PTSD. This work meets a key VA
RR&D priority of providing quality care to Veterans. Positive study results may help shape clinical practice of
cognitive rehabilitation in terms of treatment strategy, delivery platform, access to care, and means to predict
treatment response. Such impacts will translate to significant cost-savings for the VA healthcare system and
improvement in quality of life in Veterans.

Public health relevance
Veterans with mild traumatic brain injury (mTBI) and post-traumatic stress disorder (PTSD) commonly experience cognitive impairments including attention and executive function deficits that interfere with their ability to engage in productive personal and social activities. Of the limited interventions available to address cognition, none rigorously train attention beyond strategy management. This study will evaluate an innovatively combined strategy training known as Goal Management Training plus computerized attention training in Veterans with mTBI/PTSD. Preliminary testing suggests an effectiveness in improving problem solving, attention and functional tasks in a small number of Veterans. Considering these promising results, cost effectiveness, and the demand for access to care from Veterans living in rural areas, a Randomized Controlled Trial will determine and compare the effects of this treatment, administered either in-person or via telehealth, on executive function, attention, other aspects of cognition and real life functional tasks.